Flicker photophobia as an experience of inefficient coding

Project Summary
A canonical feature of migraine is visual discomfort (i.e., “photophobia”), with particular sensitivity to ﬂicker
(time-varying modulations of light). We lack a mechanistic understanding of this symptom generally, and
speciﬁcally require a framework that unites the phenomenon of discomfort with the properties of the visual
environment, perception, and neural response. Such a synthesis may be offered by recent work in information-
optimal representation. Computationally “efﬁcient” representations represent the statistical structure of the
environment and maximize sensory information storage. Recent research in experimental psychology has
shown that these “efﬁcient coding” models account for aspects of human sensory judgments and the properties
of neural activity. Importantly, these models explain how changes in the statistics of the visual environment to
lead to changes in perception. Our project is motivated by the idea that photophobia is an experience of
“inefﬁcient” information processing. Over three Aims we will apply the efﬁcient coding framework to understand
the properties of ﬂicker exposure, perception, and neural representation in typical observers and in people with
migraine and photophobia. Using personal light-logging devices, we will test the idea that people with migraine
and photophobia experience a systematically different visual world. Using psychophysical and discomfort
measures we will test for the effects of stimulus properties upon ﬂicker perception, and for differences between
people with migraine and headache free controls. Finally, we will examine the neural representation of visual
ﬂicker using functional MRI to test for the signature of efﬁcient coding in distributed neural responses.

Public health relevance
Project Narrative People with migraine and other neurological diseases often experience disabling discomfort from flickering light. This discomfort may be due to a mis-match in the brain between sensory expectation and experience. To test this idea, we will use personal light-logger devices to measure the visual environment of people with and without migraine, and then test predictions regarding the perception and brain responses to flicker found for these two groups.